Modulation of the gut microbiome by dietary fiber to improve calcium absorption and bone health in older men

Osteoporosis and associated fractures are key health problems in older male Veterans due to high morbidity
and mortality, yet little is known about the pathogenesis of accelerated bone loss in men. Emerging evidence
points to dietary fiber as an important modifiable risk factor, likely through increased intestinal calcium
absorption as suggested by studies in adolescents, young men, and postmenopausal women. It remains
unknown whether dietary fiber augments calcium absorption and bone health in older men, in part because we
do not have a clear mechanistic understanding of how it influences calcium and bone metabolism. The gut
microbiome, which is crucial for host nutrient metabolism and hormone modulation, is an underexplored
mechanism. Dietary fiber intake is associated with increases in short chain fatty acids (SCFA) that are
produced by microbiota fermentation of dietary fiber in the lower intestine. Among other effects, SCFA can
induce host insulin-like growth factor 1 (IGF-1) synthesis, which is a regulator of calcium absorption and bone
metabolism. Therefore, our central hypothesis is that dietary fiber augments SCFA production by the gut
microbiome, which modulates the production of systemic IGF-1 to increase calcium absorption and bone mass.
To test this hypothesis, we will first evaluate the effects of soluble corn fiber on intestinal calcium absorption
and gut microbiome composition and function in older male Veterans. With a crossover intervention study, we
will measure fractional calcium absorption using dual isotopic tracers and characterize the gut microbiome with
shotgun metagenomics and metabolomics after 4 weeks of soluble corn fiber and placebo (Aim 1). Second, we
will determine the causal role of the gut microbiome in calcium homeostasis and bone. We will measure the
differences in calcium absorption and bone microarchitecture, assessed by an in situ ligated intestinal loop
procedure and microcomputed tomography, between an antibiotic-induced microbiota-depleted mouse model
vs. control after 8 weeks on soluble corn fiber-supplemented diet, fiber-free diet, or control diet (Aim 2). Third,
we will explore the mediating role of IGF-1 by measuring the change in serum IGF-1 level while on soluble corn
fiber in the older male Veterans studied in Aim 1, and then with a transgenic mouse model with intestinal IGF-1
receptor knockout (Aim 3). Results from the proposed research are expected to provide valuable insights into
the effects of dietary fibers on calcium and bone metabolism and the mediating role of the gut microbiome.
Further, the proposed activities will promote the career development of Dr. Wu, a staff endocrinologist at the
San Francisco VA Health Care System (SFVAHCS) with the long-term career goal of becoming a
clinical/translational VA investigator of the interactions between nutrition, gut microbiome, and skeletal
metabolism. To achieve this goal, Dr. Wu will gain crucial training in (1) interventional study designs, (2)
advanced techniques for assessing calcium metabolism, (3) integration of multi-omics microbiome data and
computational analysis, and (4) use of mouse models for translational microbiome and metabolic research. Dr.
Wu will thrive with the support of a renowned clinical and translational mentorship team; experiential and
formal didactic training; and the outstanding scientific environment of the SFVAHCS Endocrine Research Unit,
the Benioff Center for Microbiome Medicine at the University of California, San Francisco (UCSF), and the
UCSF Clinical and Translational Science Institute. By the end of this award, Dr. Wu will have the necessary
skills and preliminary data to compete successfully for Merit Review funding and to establish an independent
VA research career.

Public health relevance
Osteoporotic fractures are a major but underrecognized problem in men. Nearly 12% of male Veterans over age 75 years have osteoporosis, double that of the non-Veteran population. There is growing evidence that low dietary fiber intake is a modifiable risk factor for age-related bone loss in men. Preclinical and human studies in adolescents and postmenopausal women suggest that dietary fiber intake influences bone metabolism by modulating the gut microbiome to augment intestinal calcium absorption, but it is unclear through what molecular mechanism and whether dietary fiber has the same effects in older men. Due to the severe consequences of fragility fractures, it is critical to explore the effects of fiber on calcium homeostasis and the role of the gut microbiome to optimize skeletal health in older men. This research will shape the clinical care of male Veterans, inform recommendations for dietary fiber intake and bone health, and guide future scientific investigations into the relationship between nutrition, the gut microbiome, and bone biology.